Translational Science Biocore

PROJECT SUMMARY / ABSTRACT
The mission of the Translational Science Biocore (TSB) is to facilitate cancer research by providing
comprehensive services that enable cellular and molecular characterization of animal models and human-
derived biospecimens. Aim 1 is to collect, annotate and distribute human-derived biospecimens. TSB operates
with Institutional Review Board (IRB) approval to collect, store, annotate and distribute a wide variety of human
tissues and body fluids that meet specified quality parameters. In the current Cancer Center Support Grant
(CCSG) cycle, we expanded our protocol to enhance patient consenting and improve access to tissue and linked
clinical data across multiple resources and repositories. TSB is authorized to serve as an ‘honest broker’ to
provide investigators with clinical annotations that are coded to protect patient confidentiality. TSB also provides
these services to UWCCC members with project-specific, IRB-approved protocols, such as investigator-initiated
as well as national clinical trials. Aim 2 is to construct and distribute disease-specific tissue microarrays (TMAs).
TSB pathologists review archival tissue blocks to identify specimens well suited for inclusion in each TMA which
is then constructed by TSB staff. In the current CCSG cycle, 57 new TMAs with annotated clinical data were
created, bringing the total to 115 which was facilitated by the purchase of an automated microarrayer funded by
an NIH S10 award (S10OD023526). Aim 3 is to provide high quality services, expertise, and infrastructure in
cellular, molecular, quantitative, and computational pathology. TSB pathologists and expert staff guide project
development, conduct experiments, and interpret data that utilize human- and/or animal model-derived
biospecimens. Our broad expertise and services span histopathology, morphometric analysis, quantitative
analyses of specific molecular phenotypes, in situ hybridization, immunohistochemistry, and cell line
authentication. TSB houses state-of-the-art instrumentation required for each of these services. During this
CCSG cycle, TSB upgraded its digital pathology whole slide scanner and purchased systems to expand spatial
and molecular profiling services. Impact on UWCCC: During the current CCSG cycle, TSB has supported the
research of 129 unique UWCCC program members across all six scientific programs and distributed over 4,800
biospecimens. These members held 431 cancer-relevant research grants totaling $65.6M in annual direct costs,
including 142 NCI grants, during this interval. By combining human and animal pathology cores from the previous
CCSG cycle into central management with improved efficiency/coordination, we have increased the number of
members served, types of biospecimens collected, number of samples processed/distributed, and the number
of protocols/clinical trials supported. We have increased TMA creation and offer new spatial and molecular
profiling services enabling members to perform innovative research that advances the UWCCC mission.
Continued CCSG support allows us to provide members with priority access to biospecimens, extensive
pathology services at low-cost and expert consultative support for their research needs.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.